DEVELOPMENT OF PEROXIDASE OXIDATION SYSTEMS IN MUTATION ASSAYS

Mechanisms of metabolism other than those mediated by the mixed function oxidases may be important in activating certain chemicals to their ultimate carcinogenic form. Prostaglandin H synthetase is being used to activate compounds in mammalian cell mutation assays. Initial experiments showed hydrogen peroxide with sodium pyruvate. Using 5-phenyl-4-pentenyl hydroperoxide as a substrate, we have observed the mutagenic response to several chemicals. The possible mechanisms responsible for the formation of mutagenic metabolites induced by prostaglandin H synthetase as well as the mutation spectrum are being elucidated.